Novel mechanisms to limit thrombosis by decreasing fibrinogen or suppressing fibrin matrix formation

SUMMARY/SCOPE OF WORK
BACKGROUND AND SIGNIFICANCE: Thrombotic diseases are the leading cause of death and disability
worldwide. Genetic, environmental, and pharmacological factors, as well as acute and chronic inflammatory
diseases, are linked to exacerbated thrombosis. Despite this heterogeneity of etiology and risk factors,
thrombosis pathogenesis converges on a common pathway culminating in the conversion of soluble fibrinogen
to an insoluble fibrin matrix that serves as the primary structural component of blood clots. However, there are
currently no therapeutic approaches that directly modulate fibrinogen.
RATIONALE: Thrombosis risk and severity are increased substantially with elevated circulating fibrinogen levels
and other perturbations that promote the formation of a dense fibrin network that is resistant to degradation. This
proposal is based on the concept that fibrin(ogen) can be directly targeted to produce porous fibrin clot structures
with poor red blood cell retention and enhanced susceptibility to fibrinolysis with the ultimate goal of reducing
thrombosis across diverse settings regardless of other confounding sequelae. The central hypothesis is that
specific and selective reduction of circulating fibrinogen levels or directed suppression of fibrin matrix formation
significantly protects against venous and arterial thrombosis while maintaining hemostatic potential.
SPECIFIC AIMS: Innovative studies will be performed using (i) a newly developed lipid nanoparticle delivery
system of a small interfering RNA (siRNA) that knocks down fibrinogen to any desired target level and (ii) genetic
and pharmacological strategies (mRNA delivery) utilizing a customized fibrinogen variant (fibrinogenLOCK) that
suppresses fibrin polymerization. These approaches will be used to uncover the contributions of fibrinogen and
fibrin matrix formation in the development of venous and arterial thrombosis as well as to hemostasis and platelet
plug formation. The specific aims are to: (1) Determine the changes in venous and arterial thrombus formation
following targeted reduction in circulating fibrinogen or selective suppression of fibrin matrix formation; (2)
Determine qualitative and quantitative changes in bleeding and platelet plug formation during hemostatic
challenges following fibrinogen reduction or suppression of fibrin matrix formation; (3) Determine the efficacy of
fibrinogen reduction or introduction of fibrinogenLOCK in mitigating thrombosis during endotoxemia (acute
inflammation) and sickle cell disease (chronic inflammatory disease).
EXPECTED OUTCOMES AND DELIVERABLES: This work will provide novel mechanistic insight into how
quantitative and qualitative changes in circulating fibrinogen or fibrin matrix formation alters thrombogenesis.
Moreover, the proposed studies will provide essential preclinical data on a novel management strategy for
thrombotic disease across diverse etiologies. We expect to demonstrate that knocking down fibrinogen or
introducing a polymerization-suppressing fibrinogen mutant mitigates thrombosis without impairing hemostasis,
even in the context of pro-thrombotic acute and chronic inflammatory diseases.

Public health relevance
PROJECT NARRATIVE Thrombosis is the uncontrolled formation of a blood clot that blocks a vessel, often linked to inflammation and inflammatory disease, and is the leading cause of death and disability worldwide. The primary goal of this research program is to determine mechanisms linking fibrin(ogen) to thrombus formation and hemostasis using new tools that selectively reduce circulating fibrinogen or specifically suppress fibrin matrix formation. This research is highly relevant to public health as it will foster creative discoveries for minimizing the morbidity and mortality associated of thrombotic diseases, including inflammation-associated thrombosis, while providing critical insight into new anti-thrombotic treatments that are expected to be safer than the current options.